Single-cell congruence evaluation and selection of cancer models towards precision medicine

Abstract
Cancer models, such as cell lines, patient-derived xenograft (PDX) and patient-derived organoids (PDO), are
instrumental substitutes for human studies in cancer research. Whether a specific cancer model mimics tumors
in human patients and how to quantify the congruence are urgent and unsettled questions. With an increasing
number of cancer models available, how to authenticate and select the most representative model using
molecular profile information is an emerging issue. In the literature, nascent approaches are appearing through
association-based or machine-learning-based approaches. While providing partial answers, existing tools have
significant shortcomings that limit the potentials of rich cancer model resources towards translational and
preclinical research. To decipher congruence evaluation at the level of intratumor heterogeneity and tumor
microenvironment, we propose a comprehensive framework to determine molecular credentials and selection
of cancer models and to guide translational and clinical applications using single-cell RNA-seq data. The
specific aims are: (1) Identify and clinically annotate prevalent subclones and tumor microenvironment cell
types in breast cancer. (2) Perform subclone-based congruence and selection for cancer models. (3) Decipher
temporal changes in congruence of patient-derived models.

Public health relevance
Project Narrative Cell lines and other cell-based cancer models are extensively utilized in cancer research as substitutes for human studies, expediting biological and clinical findings. In this project, we aim to quantify congruence and authentication to select the most representative cancer model using molecular profiles from omics and single- cell technologies. This selection will facilitate research towards understanding tumor mechanisms, personalized treatment, and accelerated drug discovery.